Innate Sensing of Cell-Free DNA and the Interferon-Mediated Control of HIV In Vivo

PROJECT SUMMARY
While the advent of antiretroviral therapy (ART) has dramatically reduced the morbidity and mortality
associated with HIV infection, a cure is not achieved due to the persistence of latently-infected cells during
treatment. Accumulating data suggest that HIV-infected individuals often experience persistent immune
dysregulation, chronic inflammation, and accelerated aging even in the setting of ART-mediated viral
suppression. These realities have created a pronounced interest in developing strategies to cure HIV infection.
Identifying the host molecular determinants of HIV persistence and rebound kinetics following cessation of
antiretroviral therapy (ART) will be critical in developing effective strategies to cure HIV infection. We recently
applied a comprehensive systems profiling approach to plasma samples from HIV-infected individuals who
underwent analytical treatment interruption (ATI), to identify circulating host factors that enable prediction of
HIV rebound kinetics following ART interruption, and serve as potential pharmacological targets to promote
durable virologic remission in the absence of ART. The host factor exhibiting the strongest statistical
association with HIV rebound timing following ART cessation was circulating cell-free DNA (cfDNA) in
plasma. Specifically, increased cfDNA abundance in plasma was associated with delayed time-to-rebound.
cfDNA, released into circulation during programmed cell death, has been exploited extensively in the realm of
clinical oncology (often termed “liquid biopsy”). However, cfDNA remains largely unexplored in the setting of
HIV infection. In this R01 proposal, we rigorously explore cfDNA as a biomarker of HIV disease states, and we
investigate the molecular and immunologic mechanisms linking cfDNA to viral expression and rebound.
Our central hypotheses are that 1) cfDNA reflects the death rate of HIV-infected cells in vivo; and 2)
cfDNA promotes an antiviral state in the host (e.g. induction of type I interferon response) which
prevents viral rebound. Our project features an investigative team with basic, translational, and clinical
expertise, and leverages large collections of clinical samples from well-characterized HIV-infected individuals.
In Aim 1, we will apply next-generation sequencing (NGS) approaches to plasma samples from HIV-infected
individuals to validate and enhance the prognostic significance of cfDNA as a biomarker of natural HIV control
in vivo. In Aim 2, we will evaluate how the uptake and sensing of cfDNA by HIV target cells impacts cell fate
and the reactivation and replication of HIV. In Aim 3, we will determine how HIV-associated mitochondrial
dysfunction leads to cfDNA extrusion and ultimately induces type I interferon responses that prevent HIV
rebound. Our project will advance the development and evaluation of HIV cure strategies.

Public health relevance
PROJECT NARRATIVE While the advent of antiretroviral therapy (ART) has significantly decreased the morbidity and mortality associated with HIV infection, a cure is not achieved, and ART must therefore be taken on a lifelong basis. In this project, we pursue the hypothesis that circulating cell-free DNA in plasma that can be conveniently and non-invasively measured will enable us to predict if and when HIV will rebound when an individual stops taking ART. In addition, we pursue the hypothesis that cell-free DNA that circulates throughout the human body may transmit key signals that activate antiviral immunity and prevent HIV recrudescence when ART is stopped.